Identification of AD-risk genes affecting endolysosomal and lipid homeostasis pathways

Abstract/Summary
This supplement proposal will provide a critical and timely opportunity to take advantage of the wide expertise,
diverse experimental systems, substantial emerging datasets, and novel impactful findings made by the FunGen-
AD consortium. It will support one part of a multi-group collaborative project across the consortium that was not
envisioned when the individual grant applications were made but has emerged through information and data
sharing within the consortium as each individual project has progressed. The FunGen-AD external advisory
board (EAB) has recognized the value and is fully supportive of this collaboration within the consortium.
Substantial emerging data support the critical role of the endolysosomal pathway (ELP) and its role in
lipid homeostasis (LH) in the development and progression of Alzheimer’s disease (AD). Studies in human brains
have highlighted changes in the ELP and LH among the first changes in AD, suggesting that these functionally
integrated pathways might provide a target for early intervention. Genome-wide association studies (GWAS) of
AD have already highlighted several strong candidate risk genes that are central to ELP/LH, including APOE,
SORL1, and BIN1. Over the course of the functional analyses conducted within the FunGen-AD consortium, the
role of other known AD-relevant genes, including PICALM, LRP1, and CD2AP have underscored the importance
of the ELP/LH pathway. Studies to date indicate that we need to identify more genes implicated in the ELP/LH
and their impact on different neural cell types. The results could be transformative in the search for viable targets
to combat AD. The ELP/LH systems play critical yet distinct cell type-specific roles in the brain. Hence, a single
variant can disrupt ELP/LH in neurons, glial, and vascular cells in different ways. In Aim 1, we will conduct a
CRISPRi screen of c.1,000 candidate AD-risk genes in individual human iPSC-derived cell types: neurons,
astrocytes, microglia, vascular endothelial cells (ECs), and pericytes. This will comprehensively identify risk
genes important for ELP/LH in each major neural cell type. The data will be integrated with that from other
collaborating groups, prioritizing genes for additional screens and in-depth functional analyses. Our group is
particularly focused on the role of AD risk genes in vascular pathology, which is a prevalent early contributor to
AD. Effective ELP/LH function is essential to maintain vascular health, blood brain barrier integrity, and regulating
vascular inflammatory status, thus maintaining neural cell health and function. Hence, in Aim 2, we will examine
a prioritized subset of ELP/LH genes in the context of vascular ECs. We will perform in-depth characterization
of functional outcomes following knockdown of ELP/LH hits in iPSC-derived 2D vascular and 3D neurovascular
models. The CRISPR screen and characterization data will be aligned with and inform collaborative studies of
the ELP/LH across FunGen-AD groups. Through this collaboration we will gain an in-depth understanding of the
genes involved in ELP/LH function, how they act in individual neural cell types, and how the pathway can be
manipulated and effectively targeted for therapy development.

Public health relevance
PROJECT NARRATIVE In Alzheimer’s disease, brain cells are unable to absorb or degrade molecules properly, leading to abnormal accumulation of lipids and toxic proteins and thus to cell death and impaired memory and cognition. Today, we do not yet have a full accounting of the molecules involved in these processes, nor how they act within specific types of brain cells. Here, we propose to perform a large-scale screen to identify the molecules responsible in brain and vascular cells. We will then perform in-depth functional studies to define how these molecules act in the brain and uncover effective ways to prevent the progression of Alzheimer’s disease.